Impact of high deductible health plans and COVID-19 on alcohol use disorder treatment access, outcomes, and disparities

PROJECT SUMMARY/ABSTRACT
Excessive alcohol use is the 5th-leading risk factor for premature death and disability. The health and
economic burden associated with alcohol use is concentrated in ~14 million adults with alcohol use disorder.
Pharmacological and behavioral interventions, especially when combined, reduce alcohol use and related
harms and assist long-term recovery. However, only ~5% adults with alcohol use disorder receive formal
treatment in health care settings. Recent societal phenomena, namely the rapid rise of high-deductible health
plans and the 2019 novel coronavirus pandemic (COVID-19), might contribute to delayed alcohol use disorder
diagnosis and treatment. Deferred care might especially affect disadvantaged populations such as low-income
and rural residents. In the last decade, high-deductible plans requiring potentially prohibitive out-of-pocket
payments for alcohol use disorder services have expanded rapidly, now covering 57% of workers. The COVID-
19 pandemic led to stay-at-home orders and closure of nonessential businesses, dramatically reducing
healthcare use.
The overarching goal of this proposal is to examine major societal factors affecting alcohol use disorder
treatment access and disparities, including modifiable high-deductible health plans and the COVID-19
pandemic. The study will assess alcohol use disorder-related measures before and after 2 key change dates of
interest: the date that employers mandate a switch to high-deductible health plans (using a rolling cohort
accrual period), and March 2020 when COVID-19 pandemic-related restrictions began. More specifically, the
project seeks to: (1) determine the effect of high-deductible health plans on alcohol use disorder diagnosis,
treatment, and adverse outcomes; (2) assess whether high-deductible health plans increase disparities in
alcohol use disorder diagnosis, treatment, and adverse outcomes; and (3) examine the 4-year impact of the
COVID-19 pandemic on disparities in alcohol use disorder diagnosis, treatment, and adverse outcomes
The study will draw from an 18-year rolling sample (2007-2024) of ~50 million members aged 18-64
enrolled through a national health insurer. The study will apply rigorous, quasi-experimental interrupted time
series designs with segmented regression and segmented survival analyses. We expect that findings will
demonstrate the health insurance benefit designs that optimize access to AUD treatment, informing potential
modifications to Internal Revenue Service regulations that exempt certain services from high out-of-pocket
costs under high-deductible plans. Findings could also help inform post-pandemic policymaking by identifying
subgroups at risk of delayed diagnosis and treatment.

Public health relevance
PROJECT NARRATIVE Excessive alcohol use is the 5th-leading risk factor for premature death and disability. Unfortunately, recent societal phenomena might contribute to worsening alcohol use disorder recognition and care. In a large, national population, this study seeks to examine the impact of high-deductible health plans and the 2019 novel coronavirus pandemic on alcohol use disorder treatment access, outcomes, and disparities.